T1D-DN KPMP Urban Rural (T1D-DN KUR) Recruitment Site

PROJECT SUMMARY/ABSTRACT
This application, submitted by a multi-disciplinary research team, responds to RFA-DK-25-022: Precision
Medicine for Type 1 Diabetic Nephropathy (U01 Clinical Trial Not Allowed). The goal of the RFA is to expand
the Kidney Precision Medicine Project (KPMP) by adding new research sites to recruit individuals with Type 1
Diabetes (T1D) at various stages of or high risk for Diabetic Nephropathy (DN) for a longitudinal study involving
research kidney biopsies at enrollment.
Our institution is well-positioned to enroll a diverse T1D population, supported by robust electronic databases
for participant recruitment and phenotype determination. We have extensive experience with clinical trials in
the T1D population, enhancing our ability to recruit and retain participants. Resources include a T1D registry
and the Expanded Rochester Epidemiology Project (E-REP), covering 27 counties in Minnesota and
Wisconsin, linking medical records for over 60 years. This includes populations from rural regions with lower
socioeconomic status, often underrepresented in clinical research We have integrated the HOUsing-based
SocioEconomic Status (HOUSES) index and Rural-Urban Commuting Area (RUCA) classifications into a
Technology-Enabled Subject Recruitment System (TESRS) to enhance recruitment efficiency from rural and
under-resourced populations. In addition, we have access to Institutional cohorts performing genetic testing
with archived samples and laboratory measurements including renal function. Support from ethicists
experienced in biorepository consent and genomic research result return, along with patient advocacy
partnerships, will help implement KPMP protocols for kidney tissue biopsy procurement.
The development of surrogate markers for early and progressive kidney injury, including novel image-based
biomarkers and cardiovascular (CV) events proposed by us aims to clarify disease pathways and identify high-
risk T1D patients for DN and CV morbidity and mortality. Results of this project may facilitate drug discovery
and has potential to improve outcomes of people with T1D DN.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY This project aims to expand the Kidney Precision Medicine Project (KPMP) by recruiting a diverse cohort of individuals with Type 1 Diabetes (T1D) at various stages of Diabetic Nephropathy (DN) from diverse socioeconomic backgrounds. By developing surrogate markers for early kidney injury and cardiovascular events, the research will improve our understanding of disease pathways and improve identification of high-risk patients. Results of this project may facilitate drug discovery and has potential to improve outcomes of people with T1D DN.